Partnering with Pregnant and Postpartum People to Co-Create a Novel Intervention to Reduce Tobacco and Cannabis Use

1R01DA057946-01A1
Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Prenatal tobacco use among non-Hispanic Black people and sexual minorities is a pressing public health problem, placing these individuals and their infants at greater risk of poor health outcomes relative to other populations. Co-use of tobacco and cannabis during pregnancy is also more common in minoritized groups and may hinder prenatal smoking cessation and postpartum tobacco abstinence. Depressive symptoms represent a modifiable factor related to discrimination, prenatal tobacco, and prenatal cannabis use that can be addressed to promote perinatal cessation and prevent relapse. To achieve true health equity, effective perinatal tobacco and cannabis use cessation interventions created in partnership with vulnerable communities are necessary. Accordingly, the proposed project is designed to achieve the following aims: (1) Guided by a community collaborative, we propose to conduct formative research on the experiences of marginalized pregnant people who use cannabis and tobacco, to contextualize the role of depressive symptoms in prenatal dual use. We will co-create an interview guide; conduct interviews with 35 pregnant and parenting people who engage(d) in dual use and experienced prenatal depressive symptoms to determine the relationship among symptoms and tobacco and cannabis use, quit attempts, withdrawal, and relapse. We will code and evaluate themes from these interviews with the collaborative. (2) Guided by a community collaborative and using an intervention mapping approach, develop an intervention targeting prenatal depressive symptoms for prenatal tobacco and cannabis smoking cessation. (3) Guided by a community collaborative, conduct a single group, proof of concept feasibility trial of a new intervention designed to address prenatal depressive symptoms to encourage tobacco and cannabis cessation. Together, we will assess needs, choose behavioral targets and review the feasibility and acceptability of the novel intervention to prepare for future evaluation of efficacy. Although there are interventions addressing perinatal depressive symptoms, extant interventions may not be appropriate or effective for pregnant people from minoritized groups who use both cannabis and tobacco. Successful intervention development needs to include members of communities disproportionately affected by discrimination as a core part of the scientific process to better address prenatal smoking cessation. Thus, the project will provide data critical for a novel intervention to reduce prenatal co-use of tobacco and cannabis. The proposed study amplifies the voices of pregnant people from communities with higher rates of prenatal depressive symptoms and dual prenatal tobacco and cannabis use who have been under-represented in tobacco treatment research.

Public health relevance
Project Narrative Using both tobacco and cannabis during pregnancy is more common in minoritized groups and can make quitting smoking in pregnancy and remaining smoke free postpartum difficult. Because depression symptoms are addressable and are also related to experiences of discrimination and trauma, we will collaborate with people from marginalized identities to understand the ways in which depressive symptoms relate to using tobacco and cannabis during pregnancy. We will then co-develop and test an intervention to address prenatal depressive symptoms to encourage people to quit tobacco and cannabis during pregnancy and stay quit postpartum.